Boston Clinical Core Site

The current proposal establishes Boston Medical Center (BMC) as the Boston core site with Beth Israel Deaconess Medical Center (BIDMC) as an affiliate site. We will participate in and enhance the AMC Consortium by recruiting patients to trials, conducting trials efficiently, collecting high-quality data, and providing leadership in developing new trials.